CE24-001, The Penn Injury Science Center

The Penn Injury Science Center (PISC) will build on its past successes as an injury control
research center (ICRC) at the University of Pennsylvania to advance our mission of reducing
injuries and violence across the lifespan through equity-centered, actionable science, outreach,
and education. The PISC is evolving and progressing to specifically focus on the integrated
application of research, training and education, and outreach to improve the lives of the
populations disproportionately affected by violence and injury. We recognize that the injuries we
study are not distributed equally across populations; historic disinvestment and other forms of
structural racism have led to marked disparities that catalyze, moderate, or mitigate the
incidence of injury, access to prevention and treatment, and ability to recover. In this next cycle
as an ICRC, we will continue partnering with Black and Brown communities in which the PISC is
situated to conduct local, actionable injury science that prioritizes public health equity and
addresses the social and structural conditions that contribute to the burden of violence and
injury these communities experience. The PISC’s outward-facing slogan of Stop It, Fix It, Live
On aligns with our mission of empowering community-research partnerships to address primary
(Stop the event), secondary (Fix the causes of the event), and tertiary (Live On in a context of
safety rather than risk) injury and violence prevention goals. The PISC is organized around
three Cores (Administrative, Outreach, Training & Education), essential Special Advisors (Equity
and Academic-City partnerships), integration with the Children’s Hospital of Philadelphia
(CHOP), and three advisory boards (Institutional Advisory Board, External Advisory Board, and
Community Action Board) as well as four embedded Research Projects and new research
development efforts. Our four Research Projects address some of the most salient injury
problems: cross-cutting violence prevention, drug overdose and adverse childhood experiences.
Across the PISC we have prioritized diversity in leadership from underrepresented groups in our
proposed Cores and Projects, as well as mentoring of developing injury researchers from
diverse backgrounds and disciplines to become scientific and programmatic leaders. By being
the hub for injury science in our University and City, our innovative approaches in the
bidirectional research-practice-policy exchange will enhance the highest caliber research,
disseminate findings, implement new practices, promote sustainable outreach activities, and
train the next generation of injury scientists to maximize the impact of our work for equitable
outcomes in disproportionately affected populations.

Public health relevance
Project Narrative The Penn Injury Science Center (PISC) will build on its past successes as an injury control research center (ICRC) at the University of Pennsylvania with the mission of reducing injuries and violence across the lifespan through equity-centered, actionable science, outreach, and education. By being the hub for injury science in our University and City, our innovative approaches in the bidirectional research-practice-policy exchange will enhance the highest caliber research, disseminate findings, implement new practices, promote sustainable outreach activities, and train the next generation of injury scientists to maximize the impact of our work for equitable outcomes in disproportionately affected populations.